Detection and Characterization of Emerging Vector-Borne Zoonotic Pathogens in Indonesia

? DESCRIPTION (provided by applicant): CDC involvement in Indonesia began in earnest in 2011 after years of limited support for the Ministry of Health's (MOH) surveillance and response to H5N1 influenza virus. Because Indonesia was recognized as a high consequence pathogen hot spot, CDC began a partnership with ALERTAsia and the Eijkman Institute of Molecular Biology through our previous cooperative agreement (CK12002) to develop an Emerging Virus Research Unit (EVRU) to understandthe role of zoonotic arboviruses in causing human disease across Indonesia. To continue to address these concerns, this project proposes to expand the discovery of zoonotic pathogens affecting humans,especially those of pandemic risk in Indonesia.

Public health relevance
Project Narrative The epidemiology and ecology of infectious disease is a priority for CDC and the Government of Indonesia (GOI). Improving local technology, pathogen surveillance, knowledge transfer and laboratory detection will improve the countryʹs capacity for local diagnosis, surveillance, research and more effective treatment. The capacity building will also increase preparedness against emerging pandemic threats and contribute to GOI on the development of national prevention strategies and to address regional disease threats Project Narrative: RFA-CK-15-001, ALERTAsia Foundation Page 1 of 1